Core B - Microbial glycan microarray core

SUMMARY: Naturally occurring anti-ABO(H) antibodies represent the most common barrier to transfusion and
transplantation. These antibodies can vary wildly in titer and specificity, resulting in distinct clinical outcomes
following ABO(H) incompatibility. Formation of these antibodies is linked directly to host interaction with specific
microbial strains that express blood group positive carbohydrate antigens. The overarching goal of Core B is to
provide tools for assessment of the role of microbial populations in driving and shaping naturally occurring anti-
blood group antibody responses and their clinical consequences. To this end we will provide microbial
microarrays for the high throughput analysis of both innate and adaptive immune interactions with a wide array
of microbial glycans. Our recent discoveries that innate and adaptive immune factors interact with a variety of
distinct microbial glycans using a platform populated with microbial glycans isolated and printed in a microarray
format have already demonstrated the utility of this approach in elucidating key host-microbe interactions. These
results recapitulate actual interactions with intact microbes. As microbial communities are numerous and diverse,
our preliminary data also importantly demonstrate that specific microbes expressing blood group antigen can be
specifically isolated from a complex microbial mixture and that microbial glycans from these microbes can be
similarly isolated, printed and interrogated for host immune factor interactions, allowing a triage approach for
printing of relevant microbes. While these preliminary data demonstrate the feasibility and utility of this approach,
most microbes that express blood group antigens are not yet represented on currently formats. As a result, to
provide the breadth of microbial coverage needed to effectively assess host microbial interactions related to
development of anti-ABO(H) antibodies and therefore directly facilitate the studies outlined in each Project of the
program project grant (PPG) program, we propose the following specific aims: Aim 1: Continue to generate
validated microarrays populated with blood group positive and negative intact microbes and their corresponding
microbial glycans. In this aim we will continue to make existing microbial microarray platforms available to each
Project, through the continued printing of these platforms that contain previously isolated blood group positive
and negative microbes. Each array platform will be validated prior to use to facilitate reproducibility and data
comparison across the entire PPG. Aim 2: Culture, characterize and isolate glycans from newly identified blood
group positive and negative microbes for incorporation into expanded microbial array platforms. In this aim we
will expand existing microbial microarrays by incorporating microbial glycans and corresponding intact microbes
isolated by the various Projects throughout the course of the proposed studies into array platforms. The
production and validation of these key microbial microarray tools will consolidate the effective use of crucial
resources and expertise, eliminating effort overlap among the PPG sites and allowing for effective analysis of
samples and data comparison across the PPG.

Public health relevance
Narrative (Core B): Naturally occurring anti-ABO(H) antibodies, which represent the most common immunological barrier to transfusion and transplantation, can vary in titer and specificity, resulting in distinct clinical outcomes. Importantly, formation of these antibodies is directly linked to host interaction with specific microbial strains that express blood group carbohydrate antigens. The overarching goal of Core B is to provide tools that facilitate assessment of the role of microbial populations in driving and shaping naturally occurring anti- blood group antibody responses and their clinical consequences. To this end, we will provide microbial arrays for the high throughput analysis of both innate and adaptive immune interactions relevant to anti-ABO(H) antibody formation.